NIDCD National Temporal Bone Hearing and Balance Pathology Resource Registry

Project summary of funded parent grant The NIDCD National Temporal Bone Hearing and Balance Pathology Resource Registry (U24 DC013983-06) is a comprehensive program to facilitate 1) recruitment of human temporal bone donors, 2) accrual and distribution of donated specimens to active laboratories, 3) development and maintenance of searchable de-identified databases including diagnoses, histopathological summaries, audiometric data and complete sets of digitized images, 4) brokering of special needs of research investigators using human otologic material, and 5) educational efforts including educational outreach to the public and interested professionals including scientists and organ procurement specialists and undertakers.

Public health relevance
We have begun the digital scanning of full temporal bone slide sets with a Leica Aperio AT2 slide scanner obtained through the bequest of a generous donor. We aim to make the raw histological material available over the internet, at resolutions comparable to those achievable while sitting at a high-quality compound microscope with a high-N.A. 20x objective.